EFFICACY AND SAFETY OF 3 DOSES OF ESTERFIED ESTROGENS ON BONE MINERAL METABOLISM

This study is designed to evaluate the benefit of esterified estrogens in combination with Ca++ on bone mineral density.